ShEEP Request for Peggy Sue by Bio-Techne

Summary We are requesting monies for the purchase of Peggy Sue instrument from Bio-Techne. This instrument allows researchers to use preprogrammed or custom protocols for automated analysis for the separation, quantitation, identification of nanogram amounts of proteins, including phosphoproteins, derived from a variety of tissues. Peggy Sue is Protein Simple’s top of the line instrument and can do both size as well as charge separation for multiple targets in up to 96 sample in one run. Neither the Oklahoma City VA Health Care System nor the affiliated University of Oklahoma Health Sciences Center have such an instrument that enables high precision, automated analysis of protein characterization from cells or tissues. Therefore, this is a truly unique and valuable resource for the scientific community at the Oklahoma City VA Health Care System. Peggy Sue will be used by seven investigators with 6 Merit grants and 1 Career Development Award. Peggy Sue will have a broad impact on several areas of research important to the health of Veterans, including quantification and characterization of proteins from immune cell subsets of systemic lupus erythematosus and Sjögren’s subjects with or without chromosomal aneuploidies; accurately and sensitively measuring changes in protein content from very small amounts of mouse osteoarthritic knee joint tissues such as the infra-patellar fat pad, meniscus, and cartilage; measuring changes in protein expression from micropunches of discrete brain nuclei following experimental manipulation for investigating chronic stress-induced pain and; quantifying necroptosis in tissues of mice to measure the levels of phosphorylated and non-phosphorylated proteins involved in age-related increase in chronic inflammation.

Public health relevance
Narrative The Peggy Sue instrument we are requesting will provide VA investigators at Oklahoma City with the latest technology for separating (by size and charge), quantifying, and identifying protein expression within diverse tissue samples. No other research institution in Oklahoma has this instrument for automated detection of protein expression within tissues. Therefore, this is a truly unique and not-presently available resource to the scientific community at the Oklahoma City VA Health Care System that will be used to identify mechanisms of multiple disease processes that affect Veterans.